Equity Implications of Lung Cancer Screening Strategies for Population Health: a Distributional Cost-Effectiveness Analysis

PROJECT SUMMARY
Low-dose computed tomography (LDCT) screening reduces lung cancer deaths. However, LDCT screening
rates are extremely low in the U.S., particularly among populations experiencing health disparities, such as
Black and low-income Americans. Critics argue that lung cancer screening guidelines do not adequately
identify those who would benefit most from screening. In 2021, the U.S. Preventive Services Task Force
(USPSTF) updated its guidelines to respond to these critiques and widen their eligibility criteria. Currently, the
USPSTF recommends LDCT annually for individuals between the ages of 50 and 80 years with at least a 20
pack-year history of smoking, and who currently smoke or have quit smoking within the past 15 years. The
American Cancer Society (ACS) expanded their LDCT screening guidelines in November 2023 to similarly
widen their eligibility criteria. The ACS and USPSTF guidelines base screening eligibility on age and smoking
history. Yet, screening strategies that use risk prediction models may more equitably identify individuals at high
lung cancer risk because they consider more factors (e.g., family cancer history). Some programs are therefore
launching efforts to assess lung cancer risk among all age-eligible individuals who have ever smoked using the
PLCOm2012 risk prediction model. Prior studies suggest USPSTF guidelines and risk prediction models are cost-
effective, but it is unclear whether health benefits are equitably distributed across subpopulations. Cost-
effectiveness analysis (CEA) often guides policy decisions but traditionally does not consider equity. Current
CEAs of lung cancer screening focus on overall health benefits without considering the distribution of benefits
across groups. Many analyses also assume ideal yet unrealistic conditions (e.g., universal screening uptake).
This project will use a novel Distributional Cost-Effectiveness Analyses (DCEA) framework, which adds an
equity dimension to standard CEA, to address limitations of previous work. The study will evaluate the equity
impact and cost-effectiveness of three real-world lung cancer screening strategies: the USPSTF guidelines, the
ACS guidelines, and an approach based on the PLCOm2012 risk prediction model. The study will consider equity
by explicitly modeling disparities in screening eligibility and uptake rates across different subpopulations
experiencing health disparities (e.g., Black Americans). The proposal has three aims. Aim 1 will assess the
equity impact and cost-effectiveness of the three lung cancer screening strategies using DCEA. Aim 2 will
evaluate trade-offs between reducing inequity and maximizing cost-effectiveness in these screening programs.
Aim 3 will create an analytical tool for decision-makers to compare the impact of various interventions on lung
cancer screening uptake, especially among historically disadvantaged groups. Overall, this project will provide
data-driven insights and tools to assist in the development of equitable and efficient lung cancer screening
programs, with a focus on improving access and uptake among populations experiencing health disparities.

Public health relevance
PROJECT NARRATIVE Although low-dose computed tomography screening lowers lung cancer death rates, it is widely underused, especially among groups experiencing health inequities. This project will adopt a new method to assess the real-world equity impact and cost-effectiveness of three different lung cancer screening strategies: the United States Preventive Services Task Force guidelines, the American Cancer Society guidelines, and an approach based on a lung cancer risk prediction model. Project results will inform lung cancer screening programs focused on equity, thereby enhancing the availability and utilization of lung cancer screening, especially for communities experiencing health disparities and bearing the greatest risk of lung cancer.